Washington University Institute of Clinical and Translational Sciences (KL2)

I. Institutional Career Development Core (KL2), 7. Project Summary/Abstract:
The goal of the Washington University (WU) KL2 Career Development Program is to provide team-oriented, competency-based, multidisciplinary mentored research training, didactic coursework, and professional development for junior faculty. Our Clinical Research Training Center (CRTC) provides educational resources and infrastructure for the WU Institute of Clinical and Translational Science (ICTS) and partner institutions. We are requesting 9 KL2 slots to support junior faculty for 2-3 years. To enhance our successful KL2, we will develop additional innovative coursework, training and career development programs across the full spectrum
of T1-T4 research, emphasizing informatics and data science, and implementation for impact. To address the regional and national CTSA goals, we propose the following specific aims:
1: Enhance the CRTC and KL2 infrastructure and programs to provide personalized, competency based,
rigorous, high-impact clinical/translational research training and skills. We will develop and
provide new curricula and training programs emphasizing implementation science for impact. We will enhance our hybrid and online courses to improve access and flexibility for trainees and share materials with ICTS partners and other CTSA hubs. (CTSA Goal: Translational Workforce Development)
2: Provide high-quality, informatics training. We will enhance our informatics and data science training(workshops, seminars, courses, certificates, and degrees), and integrate new informatics methods, tools and skills into our courses and training programs to meet individual scholar needs. (CTSA Goal: Informatics)
3: Broaden the range of research disciplines represented among investigators leading high-impact, multidisciplinary clinical and translational research teams. We will train scholars, faculty and mentors from multiple different disciplines. To expand high-impact research in a broad range of communities and populations across the lifespan, we will integrate new team-science, mentoring and leadership development into our courses and career development programs (CTSA Goals: Integrating Populations across the Lifespan)
4: Increase collaborations between the faculty, mentors, and scholars in the KL2 program and stakeholders, ICTS program functions, partners, and CTSA hubs. We will create new resources, share best practices, and advance interdisciplinary scientific teams with a broad range of skillsets to foster patient and community engaged research and training at local, regional, and national levels. (CTSA Goal: Collaboration and Engagement)
5: Demonstrate the impact of the KL2 program. We will assess the short- and long-term performance of scholars, determine the efficacy of training methods, and use this data to improve training, trainee and faculty satisfaction, mentoring, leadership and outcomes. (CTSA Goal: Methods and Processes)